Bioinformatics and Computational Biology Core

SUMMARY-BIOINFORMATICS AND COMPUTATIONAL BIOLOGY CORE:
The Bioinformatics and Computational Biology Core will support all three Projects and the Single-Cell
Transcriptomics and Epigenetics Core (SCTE) in a range of activities related to data processing, storage,
distribution and integrative analysis. A key role of the Core is to provide a centralized portal for integrative
analysis of the different omics data (RNA-seq, ChIP-seq and ATAC-seq) to be generated by the Projects
and SCTE Core. The goal is to illuminate the transcriptomic and epigenomic landscape of T cells in
response to acute and chronic viral infection, and uncover the critical regulators that determine the state or
fate of T cells. The Core will utilize advanced bioinformatics tools for the high-dimensional data matrices
generated at different stages of the immune response and in distinct tissues by the Program Project and
will apply innovative techniques to discover core regulators. The Core will assist the three Projects and
SCTE Core for experimental design, and work closely with the other Investigators to analyze individual data
sets and also the combined data set. In particular, the Core will establish a data deposit, tracking, storage
and distribution system to allow data sharing and sample tracking among all the participating laboratories.
The Core will also establish three bioinformatics pipelines to process RNA-seq, ChIP-seq and ATAC-seq
data respectively, including sequencing read mapping, quality control and peak calling. Advanced analyses
such as enhancer prediction, motif analysis and genetic network analysis will also be conducted to reveal
the key regulators critical for defining particular T cell states.